Research Education Component

Recruitment and Education Component (REC): Abstract:
The primary goal of the Research Education
Component (REC) is to identify, attract, and promote the career development of ADRD investigators. The PITT-
ADRC REC assumes primary responsibility for executing the Center’s bold vision for advancing the ADRD
research workforce with a particular emphasis on cultivating the growth of our field’s future leaders. The inclusion
and promotion of junior investigators in multiple areas of dementia research within our PITT- ADRC is an
important responsibility of our senior faculty. With over a dozen federally funded training programs (T32s) in the
neurosciences and/or aging, the University of Pittsburgh has the infrastructure for scientific mentoring and a
critical mass of trainees – both basic and clinical – with an interest in ADRD research. Through participation in
the aforementioned training programs and/or one-on-one mentorship by a senior investigator, early-stage
investigators at Pitt have many excellent opportunities to develop their skills in clinical and basic research
methodology, grant writing, and manuscript preparation. Our REC leverages these existing resources for career
development at the University of Pittsburgh by providing an additional centralized program of ADRD-specific
research mentoring and an innovative pathway for the development ADRD research leadership through the
Optimizing Scientific Careers in AD Research (OSCAR) scholars program. The REC is tightly integrated with the
Center’s cores. We view research training through a primarily apprenticeship model, where the trainees develop
through one-on-one work with their mentors, many of whom are participating faculty in other cores of the PITT-
ADRC. The REC enhances the research education occurring in the cores by coordinating trainee-wide activities,
individualizing curriculum (especially in matching clinical research activities), and devoting administrative support
to organizing events, matching mentees with mentors, and developing centralized resources for navigating the
complex clinical research and regulatory environment of ADRD research. The REC has supported 18 OSCAR
scholars since 2020. They have experienced impressive advances in their careers; two have progressed to
leadership roles in the PITT-ADRC. In this renewal we have added Co-I Kyaien Conner, PhD, director of Pitt’s
Center on Race and Social Problems. Dr. Conner. She will lead us in implementing principles of Justice, Equity,
Diversity, and Inclusion (JEDI).
This REC will have a large and sustained impact on the field by training new leaders, which is essential for
meeting the growing needs of the growing ADRD research workforce. The innovative OSCAR ADRC core leader
training program serves as a model for research education and leadership training across the ADRC network.
.